Beyond the tubulin code: Understanding how subunit diversity regulates the formation and function of microtubules

The original Project Summary (or

Public health relevance
Project Narrative) is not changed by this supplement application.